Role of novel VTA neurons in addiction-related behaviors

PROJECT SUMMARY
The ventral tegmental area (VTA) is a core component of the neural circuitry that drives goal-directed behavior,
and a primary target through which drugs of abuse modulate behavior. Although generally regarded as a
dopaminergic nucleus, about half of VTA neurons signal through release of the amino acid neurotransmitters
GABA and glutamate. These neurons are also targets of drugs of abuse but much less studied. Recent evidence
from our lab and others has begun to show that, like VTA DA neurons, activity in VTA GABA and glutamate
neurons can profoundly shape motivated behaviors. Furthermore, sub-populations of VTA neurons release more
than one of these three recycling transmitters, including neurons that co-release dopamine and glutamate, or
glutamate and GABA. The goals of this proposal are to identify how transmitter co-release from VTA contributes
to the processes underlying behavioral reinforcement, and how co-releasing neurons functionally integrate into
the mesolimbic neural circuits that regulate motivated behavior. We will use an array of genetic approaches in
combination with behavioral, anatomical, and electrophysiological assays in mice to selectively probe the
connectivity and function of discrete VTA circuits. Together this continuing research program comprises a
thorough plan to define the form and function of novel classes of VTA neurons and enhance our understanding
of how intrinsic VTA heterogeneity shapes behaviors relevant to neuropsychiatric disease.

Public health relevance
PROJECT NARRATIVE Achieving a better understanding of the neural circuitry that control motivated behavior is critical to developing new strategies to treat and prevent drug addicition and other compulsive disorders. Dopamine neurons in the VTA have been widely implicated as a common substrate of drugs of abuse, but other VTA neuron types also contribute and may represent new targets for future intervention. This continuing research program will evaluate the contribution of novel populations of VTA neurons that release and co-release glutamate to behavioral reinforcement and other processes that underlie addictions.